In vivo high-resolution mapping of the elastic moduli and tensile stress in the human cornea

ABSTRACT
The mechanical balance between the elastic properties and tension in the cornea plays a critical role in
normal vision, refractive corrective surgery, glaucoma screening, and the management of keratoconus.
Several experimental and commercial instruments are available, and they have provided clinical data that
suggest the potential values of biomechanical analysis. However, these devices offer limited quantitative
resolution and cannot characterize corneal elastic properties that are highly anisotropic, nonlinear, and
nonuniform. The overarching goal of this project is to advance optical coherence elastography (OCE) and
use this technology to measure the mechanical parameters in human corneas with unprecedented details.
Built on strong preliminary data, the new OCE harnesses extensional and flexural elastic waves guided
along the cornea and determines tensile modulus and shear modulus, as well as tension, from the profiles
and velocities of the waves. The first specific aim will develop wideband OCE using porcine and human
cadaver eyes ex vivo. Algorithms to quantify elastic moduli and tension with high precision and resolution
will be verified. The second specific aim will apply wideband OCE to obtain detailed mechanical data from
human corneas in vivo. The study will involve healthy subjects across the lifespan, ocular hypertension
patients, keratoconus patients, and subjects undergoing refractive surgeries. The potential impact of this
project is immense, as the expected data will improve our understanding of corneal biomechanics in
relation to the various natural, pathological, and interventional processes, and the technological advance
may lead to a new clinical tool that can improve the diagnosis and treatment of keratoconus, the accuracy
of tonometry, and the safety and visual outcome of refractive surgery.

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal is relevant to public health because it will generate new, comprehensive data on the cornea and develop a novel instrument, which may advance the diagnosis and treatment of keratoconus, the safety and visual outcome of refractive surgeries, and the accuracy of intraocular pressure measurement. Therefore, the proposed research is relevant to the NIH’s mission of fostering innovative research strategies to bolster the nation’s ability to treat disease.